Novel signaling molecules regulating platelet activation

The purpose of this Research Supplement to Promote Diversity in Health-Related Research is to support a
project of the applicant which is an extension of the research parent R35 grant. The applicant is Haitian American
citizen and a member of the Black underrepresented minority group. Platelets play a crucial role in hemostasis
and thrombosis, and more and more studies indicate their role in other disease states including inflammation,
cancer, and atherosclerosis. The R35 focuses on these signaling steps and how their interplay mediates platelet
activation. Understanding signaling networks and their regulation has been my research focus for the past two
decades and our group has made important contributions to the platelet-signaling field. The goal of the R35 is to
identify novel signaling molecules that regulate main signaling pathways, characterize novel signaling pathways
emanating from the same signaling molecule, and understand the differences in various tyrosine kinase
pathways in platelets. The research design for the supplement grant follows the original studies constituting the
parent grant and will be focused on research discovering novel signaling mechanisms provided by structures
within bacterial biofilms which can increase platelet activation. Enterococcal septicemia, predominantly caused
by E. faecalis, can be difficult to treat with antibiotics and lethality approaches 25% of patients if the infection is
not resolved in 30 days. This lethality rate is significantly higher than S. aureus, and the basis of the increased
mortality is not known. Not all E. faecalis blood stream infections lead to septicemia suggesting there may be
strain to strain variation. E. faecalis strains range from ubiquitous commensals of the gastrointestinal tract to
multidrug resistant nosocomial pathogens. Mobile genetic elements play an important role in converting
commensal E. faecalis into nosocomial multidrug resistant (MDR) opportunistic pathogens. Pheromone
responsive plasmids can be present in >60% of characterized pathogenic isolates and are correlated with
increased size of heart vegetations in endocarditis rabbit models by unknown mechanisms. During the
applicant's master studies in a basic bacteriology laboratory, the applicant discovered the plasmid pCF10
remodeling the E. faecalis biofilm producing densely packed rigid structures within viscous surface-attached
biofilms and lead to the production of nonattached biofilm aggregates containing viscous biofilms with rigid
structures. For the Ph.D. the applicant wants to do biomedical research including animal modeling and human
platelets. The central hypothesis is that rigid structures in biofilms and biofilm aggregates, activate platelets by
three unique mechanisms, tugging effects of multiple sites on the glycoprotein Ib/V/IX to generate thromboxane
A2 (Aim 1) and PKC for platelet activation and Y155 phosphorylation for inflammation will both contribute to
increasing thrombotic risk leading to sepsis in animals infected with plasmid-containing strains (Aim 2).
Completion of this project will aid the candidate in establishing a career in biomedical disease research and, with an
interest in education, the candidate will serve as a role model for further recruitment and training of URM scientists.

Public health relevance
The Research Supplement to Promote Diversity in Health-Related Research will support the project of a Haitian American citizen and a member of the Black underrepresented minority group designed to provide expertise in biomedical research. The project will focus on platelet signaling mechanisms to characterize the novel signaling contribution of rigid biofilm structures in increasing platelet activation and thrombotic risk during sepsis in a murine model.